Einstein-Mount Sinai Diabetes Research Center

The mission of the Pilot & Feasibility Study Program is to provide initial support for new
investigators, established investigators to explore new directions, and to enable the ES-DRC to
attract scientists from other disciplines to diabetes research. The Pilot and Feasibility (P&F)
Study Program is a vital component of the ES-DRC and has successfully promoted numerous
new research endeavors in diabetes-related areas. This program constitutes a key interface
among the Einstein, Mount Sinai and academic communities at large, and serves as a major
attraction in the recruitment of faculty and staff. From 2010 to 2018, the ES-DRC funded 22
feasibility studies from a pool of 98 applications (funding rate of 22.4%). These studies also
include targeted efforts in this project period to increase the number of applications funded at
our regional center for both basic, clinical and translational diabetes efforts. We anticipate
funding six Pilot & Feasibility grants at steady state, with three new and three continuing awards
each, typically over a two-year period. The P&F study Program has enabled recipients to obtain
data and publications that constituted the basis for successful applications for extramural
support. Under the same administrative umbrella as the Pilot & Feasibility Program, we have
established a Microgrant award Program that provides specific support for the use of ES-DRC
Core facilities. Last year, the Microgrant Program funded six awards for the use of the non-
invasive imaging component of the Translational Research Core. In addition, we also work in
collaboration with the CTSA to support Catalytic Seed Grant Awards to enhance diabetes-
specific translation research. These value-added programs further enhance diabetes directed
research efforts and provides additional enhancements to the Program. To continue these
established and new initiatives within the P&F Program, we will: 1) advertise and organize the
yearly pilot and feasibility grant competition cycle; 2) support mechanisms for interaction and
collaboration among established researchers in diabetes and related areas and for those who
are new to the field; 3) provide mentoring and guidance for investigators who are new to
diabetes research to facilitate generation of preliminary data with the goal of successful
applications for NIH funding and other funding sources; 4) communicate responsibilities and
opportunities to P&F awardees by integrating them into ES-DRC activities; 5) provide $10,000
free use of appropriate ES-DRC Biomedical Core services directly related to the funded P&F
project; and 6) manage/support the institutionally supported Microgrant and Catalytic Seed
Grant Award programs in diabetes and metabolism.